Project 1: Manipulating E-cigarette Nicotine to Promote Public Health

PROJECT SUMMARY – PROJECT 1
Historically, the tobacco industry manipulated nicotine in cigarettes to promote smoking. They are now following
the same playbook for e-cigarettes (ECs), manipulating the nicotine dimensions of concentration and form,
and more recently have begun manipulating isomer composition through the use of synthetic nicotine. These
manipulations have led to ECs with increased palatability and nicotine delivery, maximizing their appeal and
addictiveness, particularly to young people. While ECs may be a less harmful alternative for smokers who
completely switch, EC uptake, use, and addiction among young people is alarming. The overall theme of The
Ohio State University Tobacco Center for Regulatory Science is: gFlipping the Scripth: Using the Industryfs
Nicotine Playbook to Maximize Public Health. Just as the tobacco industry manipulates nicotine to create
ECs that appeal to young people, we posit that the FDA, through nicotine regulation, can make products
unappealing to young people while still providing smokers with a less harmful alternative with sufficient appeal
and satisfaction. To test this hypothesis, Project 1 (P1) will examine the unique and combined effects of nicotine
form, concentration, and isomer on EC product appeal, abuse liability, use patterns, and toxicity (Study 1), and
determine if an EC product standard requiring a minimum level of free-base (FB) nicotine (nicotine form) would
reduce the appeal of ECs for young adults but not older adult smokers (Study 2). In Study 1, using a doubleblind
crossover design, young adult (21-24 years) exclusive EC users with no/minimal history of smoking and
older adult (.25 years) cigarette smokers will vape 8 lab-prepared, tobacco-flavored liquids varied by nicotine
dimensions. Outcomes will include subjective effects, nicotine pharmacokinetics, and puffing topography. To
assess the toxicological effects of varying EC nicotine dimensions, topography data will be used in puff-playback
toxicology studies with in vitro air-liquid interface exposures for cancer, cardiovascular and respiratory disease
surrogate markers. Nicotine isomers may have different metabolic routes and rates, so we will also examine
nicotine metabolism rate. In Study 2, young adult exclusive EC users with minimal/no history of smoking and
older adult smokers will complete a single-visit, double-blind, randomized crossover trial to vape e-liquids at 2
nicotine concentrations and 2 isomer ratios, with varying FB nicotine fractions to assess outcomes of appeal. P1
is significant and innovative because it will be the first to systematically examine the impact of nicotine
dimensions (including isomer composition) on EC abuse liability, compare pharmacological, toxicological, and
metabolic profiles of nicotine isomers in humans, and determine whether regulations limiting FB nicotine fraction
in EC liquids are appropriate for the protection of public health. P1, P3, and P4 results will also inform marketing
and product regulations that reduce appeal and dissuade EC use in youth and non-users but not adult tobacco
users. P1 will address the FDA scientific domains of Product Composition and Design, Addiction, Toxicity, Health
Effects, and Behavior.

Public health relevance
The tobacco industry has historically manipulated nicotine in its products to increase their appeal and potential for addiction for the widest possible audience, including young people and non-users. They are now doing this with newer products, like e-cigarettes and oral nicotine pouches. Our center will study how these manipulations affect young people and adults, with the goal of helping the FDA develop regulations that will make these products less appealing to young people, including non-users, but not older adult smokers and smokeless tobacco users who may benefit from their use.